BLRD Research Career Scientist Award Application

The overall research program of the applicant has focused on the mechanisms underlying the increased
risk and worsened outcome of ischemic stroke in individuals with type 2 diabetes mellitus (T2DM) with a long-
term goal of finding therapies to improve blood perfusion and reduce secondary brain damage among these
patients. My current research program is an extension of a novel finding made from my lab showing that mice
with T2DM exhibited impaired leptomeningeal (LMA) collateral flow after stroke using optical imaging, mirroring
the finding in stroke patients with metabolic syndrome using CT-angiography. Through multiphoton imaging we
observed an increased leukocyte-platelet aggregates in the cerebral arterioles and increased leukocyte rolling
in cerebral veins following ischemic stroke in T2DM mice compared to normoglycemic control mice. These
events suggest that T2DM promotes neuroinflammation and formation of microthrombi after stroke and
contributes to poor cerebral perfusion and collateral flow. The applicant’s lab has made another crucial
discovery that T2DM mice exhibited defective type I and type II interferon signaling response, which attenuates
the induction of neuroprotective effect mediated by Toll-Like receptors. Since it is well known that age
diminishes the ability of many clinical therapies in inducing tolerance to ischemia, understanding the
pathological mechanisms contributing to the failure of ischemic preconditioning in T2DM may have a wide-
reaching impact on current clinically available conditioning paradigms that induce ischemic tolerance.
To that end, the projects to be pursued during the proposed funding period of this RCS award are as
follows: 1). The current funded Merit Review grant of the applicant will determine the underlying pathological
mechanisms by which T2DM-induced chronic inflammation dampens the therapeutic effect of ischemic
tolerance induction. The goal is to find critical targets to overcome the interferon signaling defect in T2DM and
restore ischemic conditioning response. 2). To investigate how chronic inflammation caused by T2DM
exacerbates stroke induced secondary brain injury, we will determine the functional role of complement
components such as the anaphylatoxin receptors C3ar/C5ar, elevated in T2DM prior to stroke, in enhancing
the transmigration of peripheral immune cells after stroke. Our study will also discern whether T2DM
chronically affects brain resident myeloid cells and increases their potential in attacking neurons and synapses
after stroke. 3). To determine the therapeutic efficacy of interventions based on pharmacological, behavioral, or
electrical stimulation in restoring neural regeneration, brain connectivity and function after ischemic stroke.
The research proposed for the next funding period will continue to support the mission of VA Healthcare
through studies that will facilitate the translational development of potential therapeutic interventions in
improving stroke outcome among service personnel and veterans with diabetes.

Public health relevance
The main goal of my research is to support the mission of VA Healthcare through studies that will facilitate better treatment of service personnel and veterans with stroke and diabetes. My research program will improve our understanding why diabetes worsens the brain inflammation in the event of ischemic stroke by looking into the molecular mechanisms involved in the process. It will also provide clues in how diabetes increases clotting after stroke, because inflammation can worsen clotting. As such, targeting these crucial mechanisms can alleviate harmful effects caused by diabetes and lessen stroke brain injury.